Immuno-Engineering: Integrated Engineering and Immunology Training

Project Summary / Abstract
This application seeks support for a training program in immuno-engineering at Cornell University. This
program supports the training of 4 pre-doctoral students who have begun their thesis research. The goal of
this T32 training grant is to provide pre-doctoral students in engineering and immunology broad
training in Immuno-engineering, from studying single molecules to whole animals, to improve the
lives of patients. The unique aspect of this program is that training opportunities are available that enhance
the interactions between engineers and immunologists, with a combination of 17 immunology and
engineering faculty will serve as faculty Trainers. They represent a range of expertise including the innate
immune response system, adaptive immune system, allergy, asthma, autoimmune and inflammatory
diseases, response to infectious agents, cell and tissue engineering, polymer chemistry, protein engineering,
biomaterials, biocompatibility, drug delivery, molecular design, fluid dynamics, whole animal imaging, micro-
nano-fabrication and technologies, and point-of-care technologies. Graduate students in their second year
and beyond will be selected from several existing graduate Fields in engineering, for support starting in their
third year. Selection will be based upon academic and research promise of the student, the quality and
relevance of their thesis work to work in immuno-engineering, and aspirations to conduct independent
research in this area. Engineering trainees can obtain a Graduate Minor degree in Immunology, and
participate in several activities related to the training theme including: a unique immuno-engineering course, a
unique clinical immersion experience, an immuno-engineering Journal Club; the Immunology & Infectious
Disease Journal Club; the Seminars in Infection & Immunity and other related to bioengineering and
immunology; ethics training; career development activities in collaboration with the Cornell BEST program
and Cornell University Center for the Integration of Research, Teaching (CU-CIRTL), and relevant external
conferences and courses. Selection of students and monitoring of their ongoing and postgraduate career
progress will be overseen by an Executive Committee and Program-assigned mentor, their Special (or thesis)
committee, and an External Advisory Board. Coupled with an exceptional tradition of dedication to training
academic researchers this program will arm trainees with comprehensive training that will make them
exceptionally well qualified to be leaders in the emerging area of immuno-engineering.

Public health relevance
Project Narrative The translation of immunology into a technology has enormous promise across a comprehensive list of fundamental and translational immunology associated problems in a wide array of diseases including chronic and acute infections, autoimmune diseases, cancer, allergy, etc. Transforming this promise into reality will occur only if there are individuals who have had an interdisciplinary training in both areas. There is therefore an urgent need for engineers trained to understand the intricacies of immunology. However, to date, this training has been occurring in an ad hoc manner. This program will provide engineering trainees with a comprehension and appreciation of the important problems in immunology, and allow them to be able to apply engineering principles to develop approaches to improve human health.